BIOLOGICAL ENERGY PRODUCTION RHODANESE INTERACTIONS W/ IRON SULFUR PROTEINS

In times of stress all living organisms, from bacteria to humans, alter their steady-state rates of energy production. The importance of the metabolic pathways by which this adaptation occurs cannot be overstated. The consequence of an inadequate energy supply is catastrophic to the individual, ultimately affected so many vital processes that death is inevitable. This laboratory has observed sufficient experimental evidence to put forth a scheme that can explain the modulation of energy production in mitochondria. The sulfurtransferase activity of he mitochondrial enzyme rhodanese is central to the scheme. It is proposed that rhodanese, which in turn is regulated by phosphorylation-dephosphorylation, controls the rate of electron transport and thus ATP production by the reversible sulfuration-desulfuration or iron-sulfur (FeS) clusters of the respiratory chain. Hence, by controlling the rate of electron transport rhodanese controls the rate of energy (ATP) pro duct ion. The specific aim of this project is to gain insight into the molecular mechanisms by which the phospho- and dephospho-forms of rhodanese interact with FeS proteins. It is intended that the kinetics of FeS cluster assembly and disassembly, catalyzed by rhodanese, will be studied. It is further intended that a novel free radical mechanism which is designed to explain the interaction of rhodanese with FeS centers will be tested by electron paramagnetic resonance (EPR) techniques.